Molecular Mechanisms and Heterogeneity in the Inferior Olivary Nucleus Development

SUMMARY
Despite the apparent uniform cytoarchitecture of the cerebellar cortex, imaging studies have revealed
discrete functional domains within it. We have recently identified numerous Purkinje cell (PC) subtypes that
occupy discrete domains of the developing mouse cerebellar cortex, providing a basis for the functional
parcellation of the cerebellar cortex. Climbing fibers, which originate from individual inferior olive (IO) nuclei,
specifically target PCs within different domains of the cerebellar cortex. A significant knowledge gap exists
regarding the molecular heterogeneity of IO neurons and the mechanisms governing their diversification.
Preliminary data suggest the crucial role of transcription factor Foxp2 in diversifying PCs and IO neurons,
leading us to hypothesize analogous heterogeneity in climbing fiber neurons. To test this hypothesis, we
propose an innovative strategy integrating single-cell RNA-seq and single-cell resolved spatial protein
profiling to develop a three-dimensional molecular atlas of the developing IO, under normal conditions and
in the absence of Foxp2. Aim 1 is centered on constructing a 3D molecular atlas of the developing IO, while
Aim 2 investigates the impact of Foxp2 loss on IO development. We anticipate that the completion of these
aims will yield a detailed spatial molecular atlas of the IO and will provide insights into the molecular
regulation of IO nucleus formation by Foxp2. This research will not only bridge the existing knowledge gap
regarding IO neurons but also enhance our understanding of the discrete connectivity and function of
different domains within the cerebellar cortex.

Public health relevance
PROJECT NARRATIVE This proposal aims to investigate the mechanisms underpinning the role of the Forkhead domain transcription factor, Foxp2, in the development of the inferior olive in mice. The research outcomes will deepen our understanding of how mutations in different FOXP2 proteins lead to a spectrum of cognitive disorders in humans.